Development of novel, daptomycin-inspired antimicrobial peptides using non-canonical amino acids

Abstract - Development of novel, daptomycin-inspired antimicrobial peptides using non-canonical
amino acids
The demand for novel antimicrobial compounds is a pressing challenge for society. However, due to
bacterial resistance development and industrial challenges, the development of new antibacterial
compounds has lagged far behind the current clinical needs. The proposed work aims to address this
problem by developing novel, antimicrobial peptides based on an already clinically approved molecule,
daptomycin, by improving the fundamental understanding of the sequence-structure-activity relationship
and implementing this knowledge in novel molecules. Specifically, the goal is to develop peptide molecules
which recapitulate the key components of daptomycin activity, i.e. calcium binding and lipid membrane
disruption, while improving both the resistance to host degradation and synthetic processes required to
create the molecules. This will be facilitated by incorporation of non-canonical amino acids into the novel
sequences. Specifically, we will characterize the efficacy of novel peptides which mimic daptomycin’s
calcium binding properties. The design of the peptides will start with a well characterized antimicrobial
peptide and graft natural and de novo designed calcium binding sequences on to the backbone peptide.
These experiments will entail the evaluation of antimicrobial activity using both laboratory and clinical
isolate strains of bacteria. Using this information, we will investigate the response of different, clinically
relevant bacteria to the peptides with the goal of optimizing efficacy. This will involve investigating
bacterial transcriptional responses to the molecules and changes in membrane permeability. We will
simultaneously characterize the biophysical properties of calcium binding and lipid interactions of the
newly synthesized peptides. In parallel, we will also develop novel sequences that mimic the lipophilic tail
of daptomycin, a key contributor to the membrane permeabilizing mechanism of action. These molecules
will be characterized using similar approaches, with additional emphasis on evaluating the effects of these
lipophilic modifications on peptide structure and aggregation in solution. We will screen a series of
aromatic substitutions using non-canonical amino acids to improve protease resistance of the molecules.
Finally, we will take the best performing sequences for calcium binding and membrane disruption and
create and optimize hybrid peptides which can leverage the benefits realized in earlier stages. These
sequences will be aggressively evaluated for efficacy against clinical isolates, potential for resistance
development, and cytotoxicity in standard and co-culture models.

Public health relevance
Project Narrative - Development of novel, daptomycin-inspired antimicrobial peptides using non- canonical amino acids We propose to develop novel, broad spectrum, antimicrobial peptides that are modeled on the clinically approved therapeutic Daptomycin and incorporating non-canonical amino acids to improve efficacy, stability, and cytotoxicity profiles. We will use a combination of synthetic peptide chemistry, biophysical analysis, and microbiological efficacy testing to develop a sequence-structure-activity relationship in these novel molecules. The goal is to gain deeper insight into the chemical determinants that drive activity of these molecules while minimizing negative side effects to yield a new class of antimicrobials for further development as therapeutics.